Nicotinic modulation of excitatory synapse development in the prefrontal cortex

PROJECT SUMMARY
Prenatal nicotine exposure (PNE) remains a pressing public health concern. At least 10 percent of pregnant
individuals in the US report smoking cigarettes (or e-Cigs) during gestation. PNE is linked to neurodevelopmental
disorders such as attention-deficit hyperactivity disorder and autism spectrum disorders. Nicotine, via cholinergic
nicotinic acetylcholine receptors (nAChRs), enhances cholinergic activity in the prefrontal cortex (PFC),
dysregulating development and increasing the risk for PFC-linked neurodevelopmental disorders. PFC-linked
neurodevelopmental disorders point at disruptions in synapse maturation leading to synaptic dysfunction.
However, the mechanisms by which nAChR signaling, and nicotine exposure, influence synapse maturation are
unknown. Our preliminary studies found that cholinergic denervation in the developing PFC impairs excitatory
synapse maturation. Additionally, we found nicotine treatment promoted synapse maturation in the absence of
glutamatergic activity. This proposal is composed of two aims which seek to test the hypothesis that postsynaptic
nAChR signaling modulates excitatory synapse maturation in the developing PFC. The first aim uses a
combination of innovative techniques including two-photon uncaging of glutamate, chemogenetics,
electrophysiology, and pharmacology to determine if the up-regulation of endogenous cholinergic activity
promotes synaptic maturation. The second aim uses two-photon, two-color uncaging of nicotine and glutamate,
electrophysiology, and pharmacology to elucidate the synaptic and molecular mechanisms involved in the
nicotinic signaling-mediated maturation of synapses. In sum, the studies outlined in this proposal will shed light
to the cellular, synaptic, and molecular mechanisms involved in the nicotine-induced maturation of excitatory
synapses. Results from this project will advance efforts towards mitigating the impact of neurodevelopmental
disorders that result from PNE.

Public health relevance
PROJECT NARRATIVE In the US, 1 in 14 pregnant people smoke cigarettes during pregnancy; prenatal nicotine exposure leads to an increased risk of developing several neurobehavioral disorders (e.g., ADHD and autism spectrum disorders). Pressingly, the cellular and molecular mechanisms by which the nicotinic cholinergic system modulates circuit and synapse maturation, and how these are dysregulated by nicotine exposure during early brain development, remain poorly understood. Characterizing the role of the nicotinic cholinergic signaling in circuit and synapse maturation will expand our knowledge of brain development and elucidate therapeutic targets to mitigate the adverse outcomes of prenatal nicotine exposure.